Effects of experimentally-induced reductions in alcohol consumption on brain cognitive, and clinical outcomes and motivation for changing drinking in older persons with HIV infection

Abstract Persons living with HIV (PLWH) are an especially vulnerable population in the COVID-19 pandemic given their compromised immune system and comorbidities (e.g., substance use, mental health issues). Currently, no research has examined how the broad impacts of COVID-19 (e.g., extended social isolation, anxiety, family loss) are affecting alcohol use and care engagement in PLWH. Further, it is unclear whether these impacts affect cognition or the brain. This urgent supplement will allow us to capture this window of opportunity and collect timely data to address these gaps. Our ongoing U01 study of a cohort consisting of PLWH and persons without HIV focusing on using a contingency management protocol to reduce alcohol consumption provides many unique strengths to support this supplement. This supplement is within the scope of the parent grant but extents the parent study by incorporating COVID-19-related questions/measures into the ongoing data collection. We will collect additional data through questionnaires, electronic at-home cognitive testing via CANTAB Connect, stress severity quantification via cortisol analysis of hair samples, and qualitative interviews. We will also conduct COVID-19 antibody tests (through blood samples) and MRIs that we conduct as part of the parent grant procedure. The specific aims of this supplement include: 1) Determine the influence of specific psychosocial factors (e.g., social isolation, loneliness, anxiety, and food and housing insecurity) on alcohol use trajectory and HIV-related health behavior and outcomes (ART adherence, and health care engagement) during the period of the pandemic and social distancing. We will also examine which baseline factors (e.g., clinical, demographic, neuroimaging, cognitive) best predict individual differences in outcome; 2) Assess the feasibility and acceptability of (1) an at-home, electronically delivered neurocognitive assessment on the CANTAB Connect system and (2) participant mail-in hair samples. For those willing and able to complete one or both of these measures, we will examine the relationships of the psychosocial factors assessed in Aim 1 on cognitive performance and/or stress severity as measured by cortisol levels from hair samples obtained from participants; 3) Obtain additional neuroimaging from participants to ensure we have data from both before and after the coronavirus crisis, and (should there be sufficient prevalence), determine whether participants found to have been infected with COVID-19 (with or without symptoms) have a greater extent of white matter hypersensitivity (WMH) on FLAIR brain MRI, along with other associated structural, functional, and metabolic brain changes (fMRI, MRS); and an exploratory aim to will conduct a qualitative interview to explore factors that are subjectively judged to be interfering with drinking abstinence and HIV medication adherence, and what might help in this regard. These results will provide valuable evidence on how the COVID-19 pandemic affects alcohol use and HIV care, in addition to changes in cognition and the brain, which can potentially inform future prevention and treatment programs during future emergency situations.

Public health relevance
Narrative As an additional but aligning part of the active U01, this supplement will collect timely data to examine the broad impacts of the COVID-19 pandemic on alcohol use and HIV care/outcomes in an aging population of people living with HIV. We will also collect data on the feasibility and acceptability of self-administered, at- home cognitive and stress testing. Lastly, our results from the FLAIR brain MRI will allow us to study changes in white matter hypersensitivity before and after the pandemic.